NYU Melanoma SPORE

OVERALL PROJECT SUMMARY
The impressive clinical successes in immune checkpoint inhibition (ICI) therapy over the last decade have not
been matched by the development of clinically useful tools to predict patient response and toxicity. The
integration of biomarkers of patient outcome and toxicity into clinical care would allow more optimal treatment
selection. The primary objective of the New York University (NYU) Melanoma SPORE is to address the urgent
need to develop and validate clinically useful, personalized biomarkers to optimally administer immune
checkpoint inhibition therapies in the adjuvant setting. We have chosen to concentrate our efforts in this area
because FDA approval of immunotherapies in this clinical context has led to a significant increase in the
utilization of these treatments with expansion of adjuvant trials to other cancers. The use of adjuvant ICI will alter
the immunobiology of melanoma and other malignancies as well. Identifying biomarkers of benefit and toxicity is
critical, timely, and promises to have broad applicability. We have made significant progress towards these aims.
In the first five years of funding, we published 155 papers (82 SPORE-related, 15 are inter-SPORE collaborative
publications); generated an additional 4 team science awards; developed a pre-treatment auto-antibodies
signature that can predict toxicity and recurrence; and supported 20 DRP and CEP awardees. The extension of
support for the NYU Melanoma SPORE for a sixth year with interim funding will facilitate the continuation of
these efforts and maintenance of our translational infrastructure to sustain progress towards our competitive
renewal. We therefore request interim funding for Projects 2 and 3 as well as support for the Administrative Core
A and the Biospecimen Core B. While continued funding for Cores A and B are necessary to maintain the
functional infrastructure that is a core strength of our program, Project 2 and 3 were selected both for the impact
of their ongoing work and their direct relevance to the competitive renewal. Project 1 of the competitive renewal
is the continuation of our current Project 3, which is focused on understanding the predictive power of serum
autoantibodies to determine response and toxicity and the underlying biology of toxicity. Project 2, which has
extracted novel genomic biomarkers of response in the setting of adjuvant therapy, directly supports both
Projects 1 and 3, where multi-omic approaches will be used to dissect tissue-based and peripheral immune
determinants of both response and toxicity. With this support we will therefore continue to advance our efforts to
solve pressing needs in the melanoma field, with the expectation that our insights can be extended to the
increasing number of ICI--treated cancers.

Public health relevance
OVERALL PROJECT NARRATIVE Physicians currently lack robust and reliable personalized tools to guide patient management in a landscape of expanded adjuvant immune checkpoint inhibition (ICI) treatment. The NYU Melanoma SPORE is directed at discovering, refining, and validating predictive and prognostic biomarkers for high-risk resected melanoma patients considering ICI treatment. The successful validation of these novel biomarkers has immense potential to improve melanoma patient clinical management and outcomes and could be extended to the increasing number of cancers treated with ICI.